The functional organization of mammalian membranes

Project Summary
Our laboratory investigates the functional organization of mammalian membranes to generate mechanistic
insights into the connections between lipid composition, membrane structure, and cell physiology. Membranes
host a major fraction of all cellular bioactivity, orchestrating myriad simultaneous, parallel tasks. This
functionality is enabled by the remarkable complexity and diversity of mammalian lipidomes, which give rise to
a unique combination of biophysical phenotypes, including membrane fluidity, tension, curvature, and lateral
compartmentalization. We aim for a predictive understanding of how lipidome features determine membrane
properties, and how these in turn regulate cell functions. Recently, my lab has revealed the surprising
complexity, diversity, and plasticity of mammalian lipodomes and have made insights into how these
determine the lateral and transbilayer organization of cell membranes. These connections have revealed
strategies for rational engineering of membrane phenotypes to guide cell signaling and behavior. Our current
and future research aims to answer the following broad questions: (1) why are living membranes asymmetric?
How is loss of lipid asymmetry functionalized? (2) what is the lateral organization of mammalian plasma
membranes (PMs), how is it regulated, and what is its purpose? (3) how are complex lipidomes regulated and
what are the pathological consequences of dysregulation? These questions have become accessible through
methodological advances in high-throughput lipidomics, quantitative advanced microscopy, and spatially
resolved fluorescence spectroscopy. For example, we determined the asymmetric composition of mammalian
PMs and its biophysical and structural consequences. Although such asymmetry appears to be a universal
design principle for Eukaryote membranes, its selective advantages are unknown. We are exploring how
membrane physical properties are coupled across asymmetric leaflets and the physiological purpose of lipid
asymmetry. We found that local, transient release of membrane asymmetry accompanies immune cell
activation and is necessary for optimal signaling: however, how transient lipid scrambling is regulated and
functionalized is unknown. In parallel, we defined structural features responsible for protein association with
ordered membrane domains and how such domains are involved in membrane traffic, protein sorting, and
signal transduction. Our experimental and computational framework allows us to investigate the structural
codes for protein affinity for ordered domains and how protein association with membrane domains facilitates
their localization and function. Finally, we have characterized the remarkable plasticity of mammalian
membranes and their susceptibility to dietary fatty acids and characterized the effects of external inputs on
membrane properties and cell function. However, how cells maintain membrane homeostasis in response to
continuous challenges from dietary and other inputs is poorly understood. Addressing these questions will
advance our understanding of the functional role of membrane organization across the tree of life.

Public health relevance
Project Narrative (Public Health Relevance) The membranes of mammalian cells have complex compositions that are required for their unique structure and vast array of functions. The research in our laboratory is focused on defining the diversity of mammalian membrane compositions and how those lipids are organized to facilitate cellular physiology. The insights from work are expected to inform therapeutic strategies for diseases associated with membrane dysfunction, including cardiovascular disease and cancer.